Molecular Neuroscience and Imaging Core

The overall goal of the UMMC Balance and Auditory Research Center (BARC) is to employ and
expand innovative molecular, cellular, and physiological approaches to the study of balance and
hearing to develop novel diagnostic and therapeutic breakthroughs and provide advanced
training and mentorship opportunities for students, residents, and junior faculty. The Molecular
Neuroscience and Imaging Core (Core B) will serve BARC-affiliated faculty, the larger
university-wide research community, and other IDeA supported faculty by pursuing two major
aims. Core B will be divided into two arms- a molecular neuroscience arm and an imaging arm.
In Aim 1, Core B will provide centralized support for mouse line genotyping and sperm
isolation/cryopreservation for mouse line protection. One of the main activities of the Molecular
Neuroscience arm is expected to be providing support for genotyping mutant mouse lines used
in experiments. Emphasis will be on performing genotyping PCR reactions quickly and
inexpensively, lessening the burden of lab technicians and students. A second main activity for
the molecular neuroscience arm will be to fill a much-needed gap in protecting irreplaceable
elements of many research programs- the mice themselves. Currently, while all investigators
should protect their mouse lines via some sort of cryopreservation, few have the capital to
rigorously preserve all lines, and many do not have the ability to protect any lines. Critically, by
ensuring novel mouse lines created and maintained by BARC faculty, faculty of the wider
UMMC institution outside BARC, and IDeA participants are protected against catastrophic
events often witnessed in the Deep South region of the US (hurricane, tornado, extended power
outages) via offering sperm cryopreservation and long-term storage at extremely affordable
prices, the Core B molecular neuroscience arm will further enhance future reproducibility of
experiments. In Aim 2, Core B will provide centralized support for specialized sample
preparation, imaging and final image analysis as a partner with each lab. This aim will be
pursued by the second arm of Core B- the Imaging arm. The Imaging arm will support specimen
preparation, data gathering, and image analysis via standard, confocal, and electron microscopy
imaging and post-acquisition image analysis. Altogether, Core B will provide a pipeline by which
technical support from the Core can be leveraged by each participating lab to effectively shift
efforts from students and technicians involved in the routine analysis of mouse genotypes and
sample preparation for imaging to efforts more directly aligned with running and analyzing final
outcomes of experiments.